Alcohol Research Training in Neurosciences

Project Summary
This is a competitive renewal application for an Alcohol Training Program in Neurosciences at the
University of New Mexico (UNM-ARTN). This program is currently ending Year 14 of support. It has
had a tremendously positive impact on graduate education at our institution and has increased visibility
of alcohol research across campus. The program provides multidisciplinary training that includes
molecular biological, biochemical, electrophysiological, imaging, and behavioral techniques. The focus
of the UNM-ARTN program is to provide training in alcohol neuroscience research. Our group has
strengths in three areas of fetal alcohol spectrum disorder research: 1. Basic mechanisms involved in
ethanol neuroteratogenesis; 2. Biomarkers of prenatal alcohol exposure; and 3. Therapeutic
interventions to ameliorate FASD-related cognitive deficits. A total of 12 faculty members from the
Departments of Neuroscience and Psychology will be directly involved in the program as core faculty.
These faculty members are well-funded and productive, and have extensive collaborative interactions
in terms of research grants, publications, and mentoring of graduate students. Students will be from
the Biomedical Sciences Graduate Program of the Health Sciences Center and the Cognition, Brain
and Behavior Program of the Psychology Department. The program will support 4 Ph.D. students per
year. The program will be overseen by Dr. Valenzuela, a steering committee composed of members
of the training faculty, and an external advisory committee. Our trainees have been very successful in
terms of obtaining individual predoctoral fellowships, presenting at scientific meetings, and publishing
in well-respected journals. Our goal is to continue to provide high quality graduate students with the
necessary training to prepare them for a successful future career in alcohol research.

Public health relevance
Project Narrative: This is a competitive renewal application for a program that will support training of graduate students for careers in alcohol neuroscience research. Alcohol abuse and addiction is a major public health problem that is responsible for a large number of illnesses, injuries, and deaths in the United States.